Role of virus-receptor interactions in determining norovirus tropism and pathogenesis in vivo

Project Summary/Abstract This proposal describes a five-year career development program for the PI, Craig Wilen, M.D., Ph.D. to with the goal of preparing him for an independent research career as an academic physician-scientist. The PI graduated summa cum laude from Washington University in St. Louis with a degree in Biology and Economics. He then enrolled in the Medical Scientist Training Program at the University of Pennsylvania where he earned his M.D. and Ph.D. in Cell and Molecular Biology. Dr. Wilen continued his training as a resident physician in the Clinical Pathology Physician Scientist Training Program at Barnes-Jewish Hospital and Washington University. During his residency elective time, he embarked on basic science research in the lab of Dr. Herbert Virgin, who will serve as the research mentor in this proposal. Dr. Virgin is the Chair of the Department of Pathology and Immunology at Washington University and is a highly experienced and productive mentor of physician-scientists and a leading expert in viral pathogenesis and immunity. Dr. Wilen will continue his postdoctoral research in this lab. Washington University provides outstanding faculty members, collaborators, and core research facilities that will foster Dr. Wilen's scientific progress and career development. First, Dr. Wilen's Career Advisory Committee comprised of Drs. Diamond, Goldberg, Randolph, and Stappenbeck has extensive scientific expertise relevant to this proposal and highly successful track records as mentors. Second, the educational resources including the Office of Postdoctoral Affairs and the Division of Biology and Biomedical Sciences will enable Dr. Wilen to acquire and develop additional scientific and professional skills. Third, the research infrastructure within the Virgin lab and Washington University core facilities will enable Dr. Wilen to efficiently and skillfully address the scientific aims described herein. In summary, Washington University provides the ideal environment and resources for Dr. Wilen to develop and establish his independent career studying how viruses interact with the immune system to cause disease. The long-term goal of this study is to understand the role of virus-receptor interactions in governing murine norovirus tropism and pathogenesis in vivo. Murine norovirus is an important model for human norovirus, which is the primary cause of viral gastroenteritis worldwide. In addition, murine norovirus has been demonstrated to trigger inflammatory bowel disease in mice with certain genetic predispositions. However, the determinants of murine norovirus tropism and pathogenesis, and the mechanism of virus- induced enteric inflammation remain unknown. During Dr. Wilen's brief time in the Virgin lab, he performed a genome-wide CRISPR screen that identified CD300lf as a receptor for murine norovirus. Dr. Wilen is co-first author on a manuscript currently under review at Science describing this finding. This work has important implications for human norovirus infection and provides an unprecedented opportunity to study norovirus biology in vivo. In this proposal we will address the following aims: Aim1. We will test the hypothesis that CD300lf is necessary and sufficient for MNoV infection ex vivo and in vivo. Aim 2. We will test the hypothesis that CD300lf-dependent infection of macrophages, dendritic cells, and B cells differentially contributes to MNoV pathogenesis in vivo. These studies will define new mechanisms of murine norovirus pathogenesis, which has important implications for both human norovirus infection and enteric immunity.

Public health relevance
Project Narrative Murine norovirus is a model system to study human norovirus which kills up to 200,000 people annually. This proposal seeks to understand how murine norovirus interacts with its receptor to replicate and spread within its host. These experiments will provide new insight into how viruses persist and interact with the immune system to cause disease.